Adolescents and Young Adults: Dilemmas, Education, and Choices Impacting Decisions (AYAs DECIDe) Study

PROJECT SUMMARY/ABSTRACT
The proposed 5-year K23 award describes a research training program for Kristina Suorsa-Johnson, PhD, a
licensed pediatric psychologist who specializes in differences of sex development (DSD). Her overarching
career goal is to become an independently funded investigator focused on improving the psychosocial and
health outcomes of pediatric patients with DSD by creating tools to facilitate patient engagement in medical
decision making through shared decision making (SDM). This award provides support for Dr. Suorsa-Johnson
to achieve the following Career Development Aims: Aim 1: Obtain expertise in SDM, including the
development of decision aids (DAs) for adolescents and young adults (AYAs); Aim 2: Gain sexual health
education training, particularly as it relates to the creation of educational materials to enhance surgical SDM;
Aim 3: Develop expertise in evaluating and implementing DAs; and Aim 4: Expand and strengthen research
leadership and management skills. To achieve these goals, Dr. Suorsa-Johnson has assembled a dedicated
team of mentors and advisors with expertise in SDM (Angela Fagerlin, PhD), SDM in AYAs (Ellen Lipstein,
MD), sexual health education (Jordan Rullo, PhD), dissemination and implementation science (Jennie Hill,
PhD), qualitative design and clinical trials (Melissa Watt, PhD and Angela Fagerlin, PhD), multi-site trial design
(Gregory Stoddard, MBA, MPH), urogenital/gonadal surgeries in AYAs (Kathleen van Leeuwen, PhD), and
DSD education (David Sandberg, PhD and Erica Weidler, MEd, MS). A person with lived experience, Noi
Liang, MBA, MCPA, is consulting to ensure all aspects of the project align with the needs of those with DSD.
DSD are congenital conditions where chromosomal, gonadal, or anatomical sex development is atypical. AYAs
with DSD make critical and potentially irreversible, life-altering urogenital/gonadal surgical decisions. However,
we know little about how AYAs approach surgical decision making and no standardized SDM resources exist.
As such, Dr. Suorsa-Johnson proposes to create and pilot a set of surgical DAs for AYAs with DSD. This will
be achieved through three Specific Aims: Aim 1: Identify informational needs and values influencing surgical
decision making for AYAs with DSD; Aim 2: Develop a set of evidence-based DAs for surgical decisions to
facilitate SDM for AYAs and their caregivers; and Aim 3: Pilot test and refine DA content, delivery, and
feasibility. This project will result in a set of surgical decision aids ready to be tested in a multi-site trial.
This project is significant because it will change how we provide care and improve engagement in surgical
decision making for this underserved, NIH-designated sexual and gender minority subpopulation. This
innovative project is the first to explore the needs of AYAs with DSD making surgical decisions from a SDM
framework and create associated decision support tools.

Public health relevance
PROJECT NARRATIVE Adolescents and young adults with differences of sex development make critical and potentially irreversible, life-altering surgical decisions about their bodies without standardized resources to support their engagement in shared decision making. To fill this gap, the proposed research will examine the decisional needs of adolescents and young adults with differences of sex development, as well as develop and pilot a set of surgical decision aids addressing identified needs. Standardized decision aid use will promote adolescent and young adult engagement in shared decision making, leading to improved care, patient health, and psychosocial outcomes.